Analysis of Glaucoma Gene Interactions

DESCRIPTION (provided by applicant): The glaucomas are a group of vision impairing diseases characterized by progressive optic nerve damage, retinal ganglion cell death, and visual field loss. Risk factors include age, family history, anterior segment dysgenesis, elevated intraocular pressure, and high myopia. The complex nature and constraints of traditional genetic approaches in humans and mammalian model systems has limited the identification of most genes that impact glaucoma. In the previous funding period we developed methodologies and tools in zebrafish to detect and study glaucoma-associated phenotypes in both embryonic and adult zebrafish. We have also isolated mutants that display glaucoma-associated phenotypes. The bugeye mutation is an example in that mutant fish show elevated intraocular pressure, high myopia/buphthalmia, optic nerve damage and progressive ganglion cell loss. In the current study we propose experiments to explore the signaling pathways that underlie the ocular phenotypes of bugeye mutants. In addition, we will explore the cell biological basis of the anterior segment and neuronal pathology. Finally, we will study one potential suppressor mutant which we identified through linkage analysis, while also pursuing the identification of other modifier genes of the bugeye phenotypes. PUBLIC HEALTH RELEVANCE: Glaucoma is a significant health problem for the US and world in general. Due to the complex nature of the disease, a full understanding of the genetic basis of the disease and knowledge of the cell biological underpinnings of the pathology is lacking. In this application, we propose experiments in zebrafish to understand the genetic basis and mechanisms of core characteristics of the disease.

Public health relevance
PROJECT NARRATIVE Glaucoma is a significant health problem for the US and world in general. Due to the complex nature of the disease, a full understanding of the genetic basis of the disease and knowledge of the cell biological underpinnings of the pathology is lacking. In this proposal, we propose experiments in zebrafish to understand the genetic basis and mechanisms of core characteristics of the disease.